4D Multimodal Image-Based Modeling for Bicuspid Aortic Valve Repair Surgery

Bicuspid aortic valve (BAV) repair is a promising surgical treatment for young adults with aortic regurgitation
(AR). However, BAV repair surgery remains underutilized and variably applied across institutions, owing in
part to the lack of a standardized approach to BAV repair planning. Currently, BAV repair planning relies
primarily on intraoperative manual measurements of the valve made by direct observation while the heart is
in an arrested state, making it difficult for the surgeon to identify defects in valve dynamics under physiological
conditions. To address this challenge, the long-term goal is to develop a multimodal 4D image analytics and
valve modeling platform that systematically characterizes pre-operative BAV morphology and dynamics and
enables patient-specific surgical planning. The overall objectives of this proposal are to (i) fill a knowledge
gap in the precise anatomical relationships between the aortic cusps, annulus, and root that make a BAV
functionally competent, and (ii) develop computational image analytics to precisely identify the patient-
specific, anatomical and dynamic distortions that cause AR so that these defects can be prioritized for risk
stratification and planning of BAV repair surgery. This work will be carried out by pursuing three specific aims:
(1) Design and assess an automated segmentation and modeling algorithm for 4D reconstruction of the BAV
apparatus from multiple clinical imaging modalities; (2) characterize the morphological and dynamic features
of BAV competence and create a machine learning method for comprehensive anomaly detection in
regurgitant BAVs; (3) evaluate a BAV repair planning system using images acquired from valve repair
procedures at three institutions. The proposed project leverages the complementary benefits of two
modalities: real-time 3D transesophageal echocardiography and 4D computed tomography angiography,
which capture both the morphological detail of the aortic cusps with high spatial resolution and the motion of
the 3D BAV apparatus with high temporal resolution. The innovation of this project is that the proposed tools
could change how BAV repair planning is carried out. Instead of relying on intraoperative inspection of the
valve while it is unpressurized, the surgeon can interactively visualize image-derived BAV models and quantify
dynamic mechanisms of AR when the valve is in a pre-operative 4D physiological state. The significance of
this research is that it could promote consistency in valve repair planning across institutions, decrease
surgeons’ reliance on intuition and trial-and-error, and thereby increase the utilization of BAV repair in young
adults. This would have quality of life advantages relative to conventional valve replacement, which requires
lifelong anticoagulation therapy (mechanical valves) or multiple re-replacements due to limited durability
(bioprosthetic valves). Ultimately, the systematic analysis of multimodal image data for computer-aided valve
defect detection will broadly benefit advancement of surgical treatments for acquired and congenital heart
disease.

Public health relevance
Bicuspid aortic valve repair is an evolving surgical treatment for aortic regurgitation that preserves native valve tissue and circumvents risks and quality of life concerns associated with conventional aortic valve replacement in young adults. The proposed research develops new multimodal four-dimensional (three dimensional + time) image analysis technology that automatically identifies the patient-specific valve defects that cause aortic regurgitation and enables the surgeon to pre-operatively visualize the motion of the bicuspid aortic valve in order to plan a valve repair surgery. This technology could potentially reduce variability in bicuspid aortic valve repair planning across institutions and increase utilization of repair as an alternative to valve replacement in young adults.